Developmental Research Program

The goal of the Developmental Research Program (DRP) of the NCI-supported Mayo Clinic SPORE in
Hepatobiliary Cancers is to support innovative, scientifically sound research projects from which findings can be
translated into clinically relevant interventions that reduce the burden of liver and biliary cancers, which are a
leading cause of cancer related deaths that continues to grow. The success of this ongoing program in years 1-
4 of funding is evident from 11 new DRP projects, with 1 advancing to a full translational project in the renewal
period. Building upon this successful track record, the DRP will continue to provide up to $50k per year ($25k
from NCI SPORE funds plus $25k from matching institutional funds) to each of 2 projects per year, with the
potential of a second year of support based on progress and promise. At least one of these awards will be to an
investigator from an underrepresented racial/ethnic group. Potential high risk/high payoff innovative concepts
are encouraged that utilize the extensive shared resources cores of the SPORE. A rigorous peer review process
utilizing the expertise of the External Advisory Board and other experienced investigators, with additional input
from the patient advocates and Community Engagement and Diversity Council, evaluates all applications based
upon the following criteria: scientific merit, originality, qualifications of the applicant/co-investigator(s), and
translational potential. Whereas the translational trajectory of all applications needs to be readily apparent, the
priority is on potentially high payoff proposals investigating all aspects pertaining to the morbidity and mortality
of hepatobiliary cancer from the bench to the population. This is accomplished through the following Specific
Aims: 1) Solicit and support the most innovative and interdisciplinary translationally relevant laboratory,
population science, and clinical studies in hepatobiliary cancer, 2) Encourage and seek out the recruitment of
qualified minorities, women, and persons with disabilities, 3) Provide critical evaluation of all DRP applications
and awardee progress, 4) Foster extensive scientific collaborations and facilitate the development of DRP funded
proposals into independent extramural applications and/or future Hepatobiliary Cancer SPORE translational
projects, and 5) Develop awardees as leaders of future SPORE projects, and as SPORE and Cancer Center
leadership. Continued support from the SPORE is expected to lead to the generation of new hypotheses that
will be tested in SPORE-sponsored research or other peer reviewed external grants. The long-term goal of the
SPORE is to translate the findings generated by these developmental projects into a reduction in the incidence
and mortality rates of liver and biliary cancers.

Public health relevance
DEVELOPMENTAL RESEARCH PROGRAM – PROJECT NARRATIVE The Developmental Research Program is an important resource to support innovative translational research in liver and biliary cancers. A rigorous process ensures transparency and fair review of applications. The program encourages inter-disciplinary proposals with high payoff potential to rapidly translate new treatment concepts to patients with liver and biliary cancers.